Neurodevelopmental Mechanisms Underlying the Onset of Depression Amount At-Risk Youth: The Role of Dysregulation in the Negative Valence System

PROJECT SUMMARY
Offspring of mothers with major depressive disorder (MDD) are at substantially elevated risk for developing
depression by early adulthood. Devastatingly, 60% of these high risk (HR) youth will meet criteria for MDD by
age 25, versus only 16% of individuals in the general population. Recognized by the 2022 NIMH Strategic Plan,
the discovery of a reliable, objective marker of MDD risk is critical for earlier detection to facilitate targeted
prevention efforts for HR youth. Across studies, HR offspring exhibit maladaptive reactivity and regulatory
responses to negative social-emotional stimuli. During functional magnetic resonance imaging (fMRI) tasks
probing negative emotion processing (NEP), youth of depressed, versus nondepressed, mothers consistently
exhibit dysfunction in brain networks responsible for adaptive NEP, including
salience emotional and cognitive
control networks (SEN and CCN). Critically, pilot data from the Early-Stage Principal Investigator provide
compelling evidence that SEN-CCN network dysfunction during NEP may represent a brain-based marker of
depression among HR youth. However, a mechanistic test of this hypothesis has yet to be evaluated in an
adequately powered and demographically distributed sample of HR and low risk (LR) youth followed over a
sufficient period to detect the emergence of MDD. The current R01 will employ a novel, multimodal, longitudinal
study to test whether functional properties of brain networks supporting NEP predict future depression
trajectories among HR and LR youth (Aim 1). In doing so, we will examine whether SEN-CCN dysfunction during
NEP changes over time once depression emerges. Clarifying the question of stability is critical to determining
whether SEN-CCN dysfunction during NEP is modifiable and may represent a novel MDD treatment target in
HR youth (Aim 2). Prior work also shows that HR youth exhibit deficits in NEP across physiological (event-related
potentials, ERPs), behavioral, and self-report indices. To determine which risk markers should be prioritized for
prevention, an innovative aspect of the proposal will be to test if SEN-CCN function during NEP is superior to
other cost-effective markers of risk in predicting youth depression, and whether a multi-indicator model including
several units of NEP improves MDD prediction indices (Aim 3). Finally, we will explore how biological sex and
puberty interact with neurodevelopmental pathways to predict depression trajectories in HR youth. To achieve
these aims, we will recruit 250 youth (with and without with a maternal history of recurrent MDD). At baseline,
youth (ages 9-14, 50% female) will be lifetime free of MDD to capture the emergence of depression during a
period of elevated MDD risk. At baseline, 12-, and 24- months, youth will complete tasks probing negative social-
emotional reactivity and regulation to generate multimodal NEP measures (fMRI, ERPs, behavior). Every 6
months, we will assess youth’s depressive symptoms and diagnoses via online surveys and phone interviews
(up to 24 months). Findings will contribute to the discovery of biomarkers that are linked to the development and
course of MDD among HR youth, which can be utilized in targeted MDD prevention and intervention studies.

Public health relevance
PROJECT NARRATIVE Offspring of depressed mothers are three-to-six times more likely to meet criteria for major depressive disorder (MDD) by early adulthood than are individuals in the general population; however, not all high risk (HR) youth develop MDD, suggesting factors that may exacerbate risk profiles. The current project combines measures of brain function, psychophysiology, and behavior across three time points during a developmental window of heightened MDD risk to study how deficits in negative emotion processing are implicated in both the development and course of depression among HR offspring. By exploring how biological sex and puberty interact with negative emotion processing styles to predict depression profiles in HR youth, findings from the current study have significant potential to inform novel prevention and intervention targets for specific populations of at-risk youth.